Plasticity of cortical circuits in health, aging, and Alzheimer's disease

Project Summary/Abstract
Comprised of six distinct layers, the cerebral cortex is the key brain structure for all of our cognitive
abilities, ranging from sensation to decision making to movement. Each layer contains distinct cell types differing
in their genes, biophysical properties, and connectivity with other parts of the nervous system. Yet how these
diverse cortical layers and cell types are involved in any given behavior remains unresolved. Moreover, we
currently lack insight into how aging impacts interactions between cortical layers, which severely limits our
understanding of how aging alters cortical circuit function. At the most basic level, the cortex can be divided into
deep and superficial layers, each of which receives a complete copy of sensory information from the thalamus.
This suggests that the two sets of layers constitute different processing systems, which begs the question: what
are the possible purposes of these parallel networks? Because these processing streams differ in input, output,
intrinsic membrane, synaptic integration, and spike generation properties, I hypothesize that deep and superficial
layers have unique, independent functions. This also raises the intriguing possibility that these pathways are
differentially susceptible to aging. I hypothesize that aging leads to layer-specific changes that ultimately lead to
unique age-related deficits in cortical circuit function.
Investigating the functions and age-related changes in deep and superficial cortical networks requires a
cortex-dependent task. In Dr. Bruno’s lab at Columbia University (F99), I developed a whisker-mediated texture
discrimination task for head-fixed mice, demonstrated that this behavior requires the cortex, and revealed that
both deep and superficial layers are involved in processing texture information (Aim 1.0, progress report). I
propose to characterize the sensorimotor strategies required for this behavior (Aim 1.1) and how layer-specific
manipulations alter texture representation in the deep and superficial layers (Aim 1.2). Understanding the
computations performed by individual layers will not only expand our understanding of the complex cortical
circuitry, but will also provide insight into how aging and neurodegeneration – which often involve dysfunction of
specific cortical cell types, layers, and their pathways – may be mitigated through the development of targeted
therapies. In Dr. Tsai’s lab at Massachusetts Institute of Technology (K00), I will develop a novel therapy that
galvanizes the brain’s own mechanisms to noninvasively improve cognitive and behavioral health in aged and
Alzheimer’s disease (AD) model mice. To do so, I will first identify how aging and AD alter learning, performance,
sensorimotor strategies (Aim 2.1), and sensory processing across cortical circuits (Aim 2.2) on my texture
discrimination task. These findings will inform the development of a noninvasive therapy that stimulates cortical
circuits to protect sensory and motor functions from aging and AD pathology (Aim 2.3). This proposal will advance
our limited understanding of how aging dynamically alters cortical circuits in vivo and may lead to an effective
intervention to prevent age and disease-related functional impairments in human patients.

Public health relevance
Project Narrative The cerebral cortex is instrumental to all human and animal cognition, ranging from sensation to decision making to movement. The complexity of cortical circuits is a major obstacle to both understanding cortical function as a whole and to treating maladies that might afflict it, including numerous neurological and psychiatric disorders. The proposed studies will reveal how cortical circuits interact to execute cortical computations, how these interactions are impaired by aging and neurodegeneration, and how we can noninvasively stimulate cortical circuits to galvanize the brain to fight against pathologies caused by aging and Alzheimer’s disease.